Length-dependent activation in human myocardium

ABSTRACT
This translational project uses human biospecimens procured from organ donors and patients undergoing
cardiac transplant to advance understanding of a cellular-level mechanism that underpins the Frank-Starling
relationship. Specifically, the project focuses on length-dependent activation, defined as the increased maximum
force and Ca2+ sensitivity of contraction induced by myocardial stretch. The mechanisms that underlie length-
dependent activation remain unclear, but may involve thick-filament regulation and transitions between the newly
discovered OFF and ON states of myosin.
Co-PI Campbell has spent a decade building a biobank that now contains >10,000 myocardial specimens from
>360 patients. Pilot experiments performed by Co-PI Tanner with these samples show that length-dependent
changes in Ca2+ sensitivity are eliminated in myocardium from patients who have non-ischemic heart failure, but
preserved in myocardium from organ donors and patients who have ischemic heart failure. New computer
modeling predicts that these functional effects reflect destabilization of the myosin OFF state in patients who
have non-ischemic heart failure. This hypothesis is supported by additional experiments that used fluorescent
polarization techniques to assess OFF/ON dynamics in the thick filaments of human myocardium. Further pilot
studies tested the effects of peptides targeted to the thick filament. Peptides that stabilize the OFF state reduced
the Ca2+ sensitivity of contraction at long sarcomere length while destabilizing peptides enhanced Ca2+ sensitivity
at short length. The length-dependence of these effects was predicted by our computer modeling.
The project builds on these data from human biospecimens and integrates the skills and resources of five
cardiovascular researchers, a statistician, and a physician-scientist who specializes in advanced heart failure.
The Aims explore the global hypothesis that length-dependent activation is reduced in patients who have non-
ischemic heart failure because their cardiac thick filaments are biased towards the ON state.
Aim 1: Test the hypothesis that length-dependent changes in Ca2+ sensitivity are reduced in myocardium from
patients who have non-ischemic heart failure.
Aim 2: Test the hypothesis that the OFF state of the thick filament is destabilized in myocardium from patients
who have non-ischemic heart failure.
Aim 3: Target OFF/ON transitions to manipulate the Ca2+ sensitivity of human myocardium.

Public health relevance
NARRATIVE This project analyzes samples of cardiac muscle procured from organ donors and patients who have heart failure. Experiments will test how the muscle contraction changes as the samples are stretched and whether the contraction can be modulated with specially designed molecules. The results of this project will accelerate the development of better therapies for patients who have different types of heart failure.